IMMUNE GLOBULIN FOR COVID-19 - UNITED STATES DEPARTMENT OF DEFENSE

The United States Department of Army supports the health of service members. Immune globulin that targets SARS-CoV-2 may provide therapeutic benefit by blocking the ability of the virus to infect and replicate in susceptible hosts. The Army will investigate the potential therapeutic impact of immune globulin for prevention of COVID-19 in service members who have recently been exposed to or infected with SARS-CoV-2.